Oklahoma Shared Clinical and Translational Resources

ABSTRACT
The Oklahoma Shared Clinical Translational Resources (OSCTR) Center at the University of
Oklahoma Health Sciences Center (OUHSC) is proposing to continue its participation and
leadership in the National COVID Cohort Collaborative (N3C). The OSCTR will contribute input
and patient-level data to N3C, including participation in privacy preserving record linkage
activities. With expertise in warehousing and analyzing large datasets, the OSCTR will continue
to connect, store, manipulate, display, report, and transmit data across multiple platforms. They
will maintain and expand the IDeA-CTR COVID Consortium, work with N3C committees,
actively engage investigators in IDeA states, and support ongoing manuscript development and
leadership roles. The OSCTR's recent accomplishments include co-authoring manuscripts,
automating data processing for N3C submission, and mentoring new data scientists. Their
planned activities involve data agreements, data ingestion and harmonization, CTR
collaborative discussions, local and collaborative N3C engagement facilitation, and obtaining
necessary institutional approvals. Leveraging their Clinical Research Data Warehouse (CRDW)
and Clinical Research Informatics Oversight Committee (CRIOC), the OSCTR will continue to
provide comprehensive OU Health data to N3C and apply innovative promotion and utilization
efforts to expand COVID-19 related research.

Public health relevance
Project Narrative. The Oklahoma Shared Clinical Translational Resources (OSCTR) Center at the University of Oklahoma Health Sciences Center proposes to continue its participation in the National COVID Cohort Collaborative (N3C) by providing input and patient-level data. Leveraging their expertise in large dataset analysis and their Clinical Research Data Warehouse (CRDW), the OSCTR aims to deliver new N3C data payloads, support N3C record deduplication, facilitate external data linking, and engage investigators in high- quality COVID-19 research projects.